Cell Cycle proteomicsin Xenopus

DESCRIPTION (provided by applicant): Proteomics has special significance for Xenopus research because key events in meiosis, fertilization and early development are regulated at the level of translation, post- translational modification and proteolysis, and not by transcription. Proteomics is the only tool for systematically investigating these levels of regulation and discovering new mechanisms. We propose to develop a cutting edge proteomic research platform for Xenopus embryos and egg extract by migrating technology developed in human and yeast systems, and to publicly disseminate the databases and tools we develop. We will also optimize methods for proteomic analysis of protein complexes and compartments in egg extract. Using these tools we will quantify relative amounts of >5,000 proteins, >10,000 phosphorylation sites and >1,500 ubiquitination sites in early development and in egg extracts under normal and perturbed conditions. We will investigate the mechanism of cell cycle regulation, how the cell cycle changes during early development, how microtubules are nucleated, and how embryos detect changes in the nucleus to cytoplasm ratio.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative We will develop broad based tools for the study of changes in the protein levels during the cell division cycle, bringing the revolutionary technique of mass spectrometry to embryonic systems. Such studies could offer a better basis for designing drugs that affect important pathways in cancer and inflammation. __SpecificAimsTextDelimiter__ 2. Specific Aims Rapid changes of protein levels and post-translational modifications, characteristic of the metazoan cell cycle, affect virtually every feature of cell physiology. Though we have learned a great deal about the core strategy of the cell cycle, we have still not identified many of the regulatory features at a biochemical level. Recent progress in mass-spectrometry (MS) allows us to investigate dynamics of protein levels and post-translational modification throughout the cell cycle quantitatively and in a global and unbiased manner. Xenopus eggs were instrumental in early cell cycle biochemistry, and still provide unique advantages: natural synchrony, sufficient material from one cell for biochemical analysis, a cell-free extract system that recapitulates complex cellular events and access to developmental changes in cell cycle regulation. To exploit these unique features with MS in Xenopus eggs and embryos will require new biochemical and bioinformatic tools, and new experimental design - the subject of this proposal. Although we focus here on the cell cycle and early embryo, our tools will enable biochemical investigation of all aspects of Xenopus biology. Aim 1: Develop a dedicated platform for Xenopus proteomics. For quantitative MS of protein abundance and we will i) perfect methods for sample preparation for Xenopus eggs and embryos, and develop workflows for quantitation using ii) tandem isobaric mass tag (TMT) labeling along with triple tandem mass spectrometry (MS-3) to read the tags with low ambiguity and/or iii) reductive methylation with quantitation occurring in the primary MS scpost-translational modification an (MS-1). To improve matching between MS data and sequence databases we will i) aggregate deep sequencing results, ii) improve annotation using algorithms for efficient data mining across experiments and iii) establish a Xenbase-hosted wiki for database annotation by qualified experts. We will disseminate all tools and databases in formats that provide easy access for the community. Aim 2: Follow dynamics of protein levels and post-translational modifications in fertilized eggs and derive pathway relationships from drug induced perturbations. Using proteomic techniques we will identify and quantify changes in >5000 Xenopus proteins, >10000 phosphorylation sites and >1000 ubiquitination sites following egg activation, with a time resolution under 1 minute. We will identify potentially interesting components of cell cycle pathways (combining prior knowledge and dynamics revealed by our data) and use selective peptide mass probes to quantify changes in those proteins in dose-response and time course experiments. Using known drugs that target components of the cell cycle engine, we will perturb endogenous reactions and derive structural information about endogenous pathways from covariation in the levels of proteins and post-translational modifications. Aim 3: Infer cell cycle and cytoskeleton pathways at the level of protein complexes and compartments in egg extracts. Xenopus egg extract is essentially undiluted cytoplasm that faithfully recapitulates the cell cycle and cytoskeleton biology of the egg while allowing biochemical perturbation and live imaging. We will evaluate and optimize methods for isolating complexes and compartments from extracts and characterize their protein contents. Our primary focus will be to develop multiplexed methods for quantifying how complexes change their composition and undergo post-translational modifications, as a function of cell cycle state and titration of small molecule inhibitors and regulatory proteins. We will then causally relate these changes to the function and dynamics of the complexes. Aim 4: The role of nucleus/cytoplasm (N/C) ratio in cell cycle changes during early embryonic development. In most cells the N/C ratio is thought to be tightly controlled by means that are not understood. In Xenopus embryogenesis the cell cycle changes dramatically in meiosis, cleavage divisions, and gastrulation. Some of these changes have been shown to be regulated by N/C ratio; it is generally thought that components of the cytoplasm are titrated by the exponentially increasing nuclei. First we will characterize the differences among the embryonic cell cycles. We will then measure the titrated components by determining the proteome of nuclei and cytoplasm from oocyte to gastrulating cells and identify those components that are depleted at the time of major cell cycle transitions.